Task A88: Cotton Rat Model for the Evaluation of Vaccines and Therapeutics for RSV and Related Viruses

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.